Optimal Stimuli as a New Method to Investigate Neural Networks

Abstract:
Cortical microcircuits are cubic-millimeter neural networks that tile the brain surface and support every aspect of
cortical function, from perception to motor skills to decision-making. As such, these circuits are theorized to form
the fundamental “computational unit” in the brain, a flexible building block that can be repeated and recombined
in new ways to achieve new functions. However, despite pioneering work investigating these microcircuits, we
still have important gaps in knowledge about the computations they perform. Partially, these gaps come from
limitations in traditional experimental designs. For example, in visual cortex, studies of cortical microcircuits have
generally used single-modality stimuli, such as oriented gratings or colors. These simple stimuli only capture a
neuron’s preferences for one type of visual feature and miss the diversity of visual features we observe in real
life. In contrast, new machine learning approaches can gather data on a neuron and design “optimal” stimuli that
incorporate a neuron’s preferences across all possible images. These approaches achieve significantly more
precision than conventional methods and have the potential to finally unravel the inner workings of cortical
microcircuits, leading to a more complete understanding of the brain for both science and medicine. However,
to date, these new methods have only been applied to individual neural preferences: they have not been used
to study how these neurons interact. Therefore, we will apply these new machine learning techniques to elucidate
how the brain functions at a circuit level. Traditionally, columnar microcircuits are understood to have
homogeneous stimulus preferences when using conventional stimuli. However, we know that these stimuli only
capture about 45% of variability in the neurons’ responses: we do not know what the full range of natural images
will reveal about these circuits. Therefore, due to differences in circuitry and cell types across cortical layers, we
hypothesize that “optimal stimuli” will finally reveal heterogeneous stimulus preferences within cortical
microcircuits, demonstrating the computations performed across these networks. Our technique combines an
image generator, which produces a diverse range of color images, and an optimization algorithm which uses
neural feedback to evolve these images and maximize the activity of a target neuron in visual cortex. Using this
technique, we aim to characterize the precise computations performed by vertical connections across layers and
horizontal connections across columns in the cortex. Overall, we propose an unprecedented study of cortical
microcircuits using new machine learning techniques and offering both scientific and medical significance.
Scientifically, our technique offers an invaluable tool for studying any stimulus-responsive brain region, providing
a systematic way to characterize unknown brain circuits as well as reevaluating known brain circuits. Medically,
this technique will empower the next generation of scientists to design more personalized interventions for
psychiatric and neurological patients, uniquely targeted to their brain and neuropsychiatric profile.

Public health relevance
Project Narrative: Conventional studies of visual cortex have used single-modality stimuli, such as oriented lines or uniform colors. In contrast, new machine learning approaches can gather data on a neuron and design “optimal” stimuli that incorporate a neuron’s preferences across all possible images. For the first time, we propose to apply these new machine learning techniques to examine how the brain functions at a circuit level, leading to a more complete understanding of the brain for both science and medicine.